Pre-Doctoral Training in Interdisciplinary Neuroscience

PROJECT SUMMARY/ABSTRACT
This proposal requests continued funding of an established Neuroscience Graduate Training Program in the
Institute for Neuroscience (INS) at the University of Texas at Austin (UT-Austin). This program is becoming a
nationally-recognized center of excellence in neuroscience training with the creation of a new Department of
Neuroscience, construction of the new Dell Medical School with Clay Johnston, a neuroscientist, as the
inaugural Dean, and recruitment of outstanding Faculty. Faculty have appointments in Neuroscience,
Neurology, Psychology, Psychiatry, Pharmacy, Computer Science, Biomedical Engineering, Mechanical
Engineering, Communication Sciences and Disorders, Molecular Bioscience, and Integrative Biology, and
resolutely participate in 8 prestigious centers that are part of the INS, including the Center for Learning and
Memory, Center for Perceptual Systems, Institute for Cellular and Molecular Biology, Waggoner Center for
Alcohol and Addiction Research, Dell Pediatric Research Institute, Behavioral Neuroscience, Imaging
Research Center, and Computational Visualization Center. The program has particular strengths in the
neuroscience of perceptual systems, learning and memory, and addiction research, and Faculty provide
excellent training across levels of inquiry from molecules to biochemistry, structure, physiology, behavior,
neuroethology, and evolution with advanced computation and theory at all levels. This breadth provides
graduate students with extensive options for training in cross-disciplinary research, and the training Faculty
have substantial funding to foster their research. We propose predoctoral funding for 4 new trainees and 4
second-year trainees (totaling 8 per year). The training program requirements include: a Boot Camp, laboratory
research rotations, seminar presentations, 2 principles of neuroscience courses, a science/ethics course
detailing responsible scientific conduct, a course in experimental design and statistics, and 4 electives
including a neuroscience of disease course. They also participate in at least 1 specialized journal club related
to their project. Students join a research lab by the summer of year 1, and complete coursework and qualifying
exams, including oral defense of a review paper at the beginning of year 2. Our recruitment strategies have
become even more successful as reflected in the quality and diversity of the applicants. The broad
interdisciplinary training uniquely prepares our trainees for research success in neuroscience, which is crucial
for advancements in the etiology, pathophysiology, and treatment of brain diseases. Furthermore, the founding
of the Dell Medical School on the UT-Austin campus will greatly facilitate our translational neuroscience
research.

Public health relevance
PROJECT NARRATIVE/HEALTH RELEVANCE The major health problems in the US result from brain diseases, including Alzheimer's, schizophrenia, alcoholism, drug addiction, depression and bipolar disorders. Incomplete understanding of the neuroscience of these conditions accounts for the limited number of effective treatments. The goal of this proposal is to provide state-of-the-art training for the next generation of neuroscientists who are equipped to solve these health problems.